Children’s Surgery Methodology And Research Training (C-SMART)

SUMMARY
Surgical trainees seeking formal research training face substantial challenges. Surgeon-scientists are an
underrepresented population in academic medicine, and federally funded physician-scientist–led research has
been in decline over the past decade. At the intersection of pediatric surgical care and scientific research, there
are very few research training opportunities for either surgical residents or PhD postdoctoral fellows. Surgical
resident training programs that incorporate protected time for dedicated experiential research training have
effectively contributed to the “pipeline” of successful, independently funded surgeon-scientists. The proposed
Children’s Surgery Methodology And Research Training (C-SMART) Program will bring together the extensive
expertise at Northwestern University’s Feinberg School of Medicine (NUFSM) and the Ann & Robert H. Lurie
Children’s Hospital of Chicago (LCH) to create a multidisciplinary, 2-year research training program consisting
of (1) a Health Services and Outcomes Research (HSOR) Track and (2) a Basic Science and Translational (BTS)
Research Track. The C-SMART Program will synergize NUFSM resources with training collaboration with
opportunities within the growing LCH Stanley Manne Children's Research Institute. Over the past 10 years, we
have leveraged this collaboration and curated a pipeline for nearly a dozen surgical research trainees and PhD
postdoctoral fellows to pursue successful academic careers at the intersection of child health and surgery. During
the proposed 2-year, intensive training period, trainees in the C-SMART Program will be immersed in
multidisciplinary, experiential research training, using a team science approach, with tailored mentorship and
focused didactic teaching (e.g., symposia, lecture series, master’s degree courses). Each trainee will have an
experienced and diverse Mentor Team of content, methodological, and clinical experts, tailored to their training
needs. The C-SMART Program core curriculum will include courses in study design and analytic approaches,
best practices and ethics in research, and career development. Trainees will participate in workshops, seminars,
and research training opportunities at NUFSM, LCH, and at relevant surgical and pediatric professional societies.
Trainees will design and execute research projects that culminate in presentations at major national conferences
and publications in high-impact journals. The program will leverage both Diversity & Inclusion and Pipeline
Committees to attract competitive applicants and foster the retention and success of trainees who are historically
underrepresented in surgery. Continuous monitoring and iterative program improvement will be achieved by
engaging a highly accomplished External Advisory Committee and through robust evaluation by Northwestern’s
Program Evaluation Core. The goal of the C-SMART Program is to increase the number of investigators who
successfully achieve academic careers as independently funded pediatric surgical scientists. NUFSM AND LCH
are uniquely positioned to ensure the success of the C-SMART Program and the continued development of
future children’s surgical scientific leaders.

Public health relevance
NARRATIVE The Children’s Surgery Methodology And Research Training (C-SMART) Program will develop the next generation of surgical scientists focused on pediatric-specific populations and diseases. The Program will provide a robust 2-year surgical research training experience curated by highly accomplished mentorship from researchers and clinicians. The C-SMART Program will be a national leader in increasing the pipeline of diverse and qualified pediatric surgeons and PhD scientists who will have successful research careers, mentor future generations of trainees, and make significant advances in the care of children.